Cardiorenal and Metabolic Diseases Research Center

OVERALL
PROJECT SUMMARY/ABSTRACT
Cardiovascular (CV), renal and metabolic diseases are inextricably linked and are the leading causes of
mortality and morbidity in the U.S., especially in Mississippi which has the highest prevalence in the nation of
these diseases. Cardiorenal and metabolic disorders usually cluster together and are highly interdependent.
Obesity and associated metabolic disorders, such as diabetes, are major causes of CV and renal disease.
Abnormal kidney function is an important cause as well as a consequence of hypertension, a key risk factor for
CV diseases such coronary artery disease and stroke. Understanding the complex relationships among CV,
renal, and metabolic disorders and developing new therapeutic approaches requires a paradigm shift in
research that incorporates multidisciplinary integrated approaches, combining the efforts of basic, clinical and
population scientists. A major objective of this Phase 2 COBRE proposal is to further develop a leading
Cardiorenal and Metabolic Diseases Research Center (CMDRC) that brings together a multidisciplinary group
of basic, clinical and population scientists working on a common synergistic theme, and to facilitate their
collaborations. The specific aims are: 1) to further develop infrastructure and core facilities that foster
excellence in basic, clinical, and population research in cardiorenal and metabolic diseases and increase
competitiveness of CMDRC investigators for independent funding from NIH and other national biomedical
research programs; 2) to enhance CMDRC mentoring and education programs and research support for
promising new investigators so that they can become productive, independent investigators who are also
effective collaborators on multidisciplinary research teams; 3) to achieve the specific aims of the research
projects described by Junior Investigators in this proposal, and to foster their career development; 4) to further
develop a pipeline of diverse postdoctoral fellows, graduate and undergraduate students trained in cutting
edge cardiorenal and metabolic diseases research so they become the next generation of researchers in this
field; major emphasis is placed on recruiting and mentoring underrepresented minority investigators through
partnerships with local institutions and by leveraging training programs at UMMC; 5) to enhance collaborations
and interactions among established investigators from multiple disciplines in cardiorenal and metabolic
diseases at UMMC, other IDeA supported programs, and external partners; 6) to strengthen cardiorenal and
metabolic disease research at UMMC by recruiting new faculty with expertise in clinical and translational
research, and in emerging technologies (e.g. in vivo imaging, bioinformatics, and systems analysis) and in
areas where there are gaps in CMDRC expertise.

Public health relevance
OVERALL NARRATIVE Cardiorenal and metabolic diseases are the leading causes of mortality and morbidity in the United States, especially in Mississippi which has the highest prevalence in the nation of these diseases. This is a critical area for research development in Mississippi in view of the emerging opportunities to develop a comprehensive, multidisciplinary research center at UMMC that focuses on these major causes of mortality and morbidity. This proposal represents a plan for continued development, via Phase 2 COBRE funding, of a unique, Cardiorenal and Metabolic Diseases Research Center (CMDRC) that is dedicated to improving lives through research, discovery, innovation, and translation to prevent and reduce death and disability from cardiorenal and metabolic diseases